Targeting breast cancer microenvironment with small molecule agonist of relaxin receptor

The therapeutics efficacy of an anticancer treatment is often restricted by tumor fibrous tissue and tumor
microenvironment. Stromal matrix barriers create a sanctuary for breast cancer, while the prolonged pro-fibrotic
stimuli facilitate cancer cell growth and survival by establishing an immunosuppressive environment. Relaxin, a
small peptide hormone, demonstrated dual anti-fibrotic and pro-immunogenic effects in various disease models
including several solid cancers. Treatment with relaxin significantly reduced the expression of major tumor
extracellular matrix components such as collagens, fibronectin, and elastin. The degradation of fibrotic tumor
matrix following relaxin treatment led to reduced cancer cell drug resistance. Additionally, it was shown that
relaxin can change tumor macrophage population from pro-inflammatory to pro-resolution enabling T cell-
mediated cancer cell killing and macrophage phagocytosis. However, due to a short half-life in vivo, delivery of
recombinant relaxin requires continuous infusion. Relaxin signals through its cognate G protein-coupled receptor
RXFP1, which is expressed in tumor associated fibroblasts and infiltrating immune cells. We propose targeting
the integrity of the tumor microenvironment with the first-in-class small molecule agonist of RXFP1 developed in
our laboratories. The lead compound, ML290, shows high activity, oral bioavailability, in vivo stability, and
excellent pharmacological properties. It is well tolerated by animals, shows no toxicity in vivo, and does not
increase cancer cell proliferation and invasiveness nor does it affect extracellular matrix remodeling in healthy
tissues. Our preliminary data indicate that the ML290 treatment of mice with HER2-positive breast cancer
reduces tumor size and tumor fibrotic content. The overall goal of this project is to demonstrate anticancer activity
of relaxin receptor agonist, ML290, in preclinical models of breast cancer, regardless of cancer subtype. We will
test the anti-cancer efficacy of ML290 in primary and metastatic breast cancer models, analyze changes in tumor
ECM composition, recruitment of immune cells, and genomic/proteomic response in stromal and cancer cells to
treatment. We will analyze the effect of combination treatment of ML290 with immune checkpoint blockade and
anti-HER2 immunotherapeutics. The pharmacological re-programing of stromal cancer microenvironment by
ML290 will provide a new therapeutic approach for breast cancer suppression.

Public health relevance
Cancer cells are protected by surrounding fibrotic stromal barrier supporting the cancer growth, suppressing the immune response, and preventing the delivery of therapeutic molecules. Our team has identified first-in-class orally bioavailable small molecule activators of relaxin receptor which demonstrate anti-fibrotic and anti- inflammatory effects. We plan to demonstrate that our lead compound may improve the therapeutic efficacy of known anticancer drugs in several preclinical mouse models of breast cancer.